Colorado Biomedical Informatics Training Program

The University of Colorado Anschutz Medical Campus Computational Bioscience
Program (CPBS) Program is an independent, Ph.D.-granting and postdoctoral training
program based in the University of Colorado School of Medicine, with a 20-year track
record of innovative and effective training of pre- and post-doctoral fellows for research
careers. We are a second-generation teaching program, informed by the experience of
the many biomedical informatics training models that have come before us. Our
program is designed to produce graduates with depth in both computational methods
and biomedicine, an intimate familiarity with the science and technology that synergizes
the two, and the skills necessary to pioneer novel computational approaches to
significant biomedical questions. We are aware of the difficulty of achieving both
breadth and depth in a reasonable amount of time, and believe we have identified a novel
approach that is capable of training productive interdisciplinary scientists in a relatively
short period. The program is tightly focused on transforming already strong students
and recent Ph.D.'s into mature and productive scientists. Our program is structured
around a set of four categories of educational goals and objectives: knowledge,
communication skills, professional behavior, and self-directed life-long learning. Our
graduates demonstrate the knowledge of core concepts and principles of biomedical
informatics, and have the ability to apply computation to gain insight into important
biomedical problems. Their knowledge includes mastery of the fundamentals of
biomedicine, clinical and translational research, statistics, and computer science, as well
as proficiency in the integration of these fields. Our graduates have contributed to the
discovery and dissemination of new knowledge. They demonstrate interpersonal, oral,
and written skills that enable them to interact productively with scientists from both the
biomedical and the computational domains, to communicate the results of their work in
appropriate formats, and to teach others biomedical informatics skills; they effectively
bridge the gap between biomedical and computational cultures. Our graduates
demonstrate the highest standards of professional integrity and exemplary behavior, as
reflected in a commitment to the ethical conduct of research, continuous professional
development, and thoughtfulness regarding the broader implications of their work. Our
unique approach to teaching computational bioethics has been adopted by many others
around the world. Our graduates demonstrate habits and skills for self-directed and life-
long learning, and recognize that biomedical informatics is a rapidly evolving discipline.
Our program itself is also undergoing continuous improvement, carefully tracking our
efforts and quickly responding to changes in the field and in our situation. We are
justifiably proud of our outstanding track record as well as of our dynamic and adaptive
approach to the training of adept, flexible, and curious scientists able to comfortably
assimilate new ideas and technologies during the course of their professional careers.
Based on our successful track record, we are requesting that our current slot allocation
be increased to 9 predoctoral, 6 postdoctoral and 4 short term positions.

Public health relevance
The University of Colorado Anschutz Medical Campus Computational Bioscience Program (CPBS) is an independent, Ph.D.-granting and postdoctoral training program based in the University of Colorado School of Medicine, with a 20-year track record of innovative and effective training of pre- and post-doctoral fellows for research careers. We are a second-generation biomedical informatics teaching program, informed by the experience of the many training models that have come before us. Our program is designed to produce graduates with depth in both computational methods and biomedicine, an intimate familiarity with the science and technology that synergizes the two, and the skills necessary to pioneer novel computational approaches to significant biomedical questions.